Autologous Non-viral CRISPR/Cas Homology-directed Repair for Artemis-deficient Severe Combined Immunodeficiency

PROJECT SUMMARY / ABSTRACT
This application for the Mentored Clinical Scientist Research Career Development Award (K08),
sponsored by the National Institute of Allergy and Infectious Diseases, describes the five-year career
development plan of Dr. Matthew Kan, a pediatric immunologist and early career physician-scientist in the
Division of Pediatric Allergy, Immunology, and Bone Marrow Transplant at University of California, San Francisco.
Dr. Kan's long-term career goal is to develop genome editing therapies for patients with inborn errors of
immunity (IEIs), and in this proposal he specifically focuses on developing a preclinical therapy for Artemis-
deficient severe combined immunodeficiency (ART-SCID).
The career development goals outlined in this application include developing expertise in non-viral
genome editing of human hematopoietic stem cells, preclinical modeling and genetic repair of ART-SCID, in vivo
delivery of genome editors, and developing potency assays for genome-edited cell products. The primary mentor
for accomplishing these career training goals is Dr. Jennifer Doudna, Li Ka Shing Chancellor's Chair in
Biomedical Sciences at UC Berkeley, who is a co-discoverer of CRISPR genome editing. Dr. Jennifer Puck,
Professor of Pediatrics, will be co-mentor, and she is a renowned clinical immunologist who is an expert in ART-
SCID and has advanced multiple lentiviral gene therapies through clinical trials. The career development plan
for Dr. Kan includes individualized mentorship, a career development team that includes other leaders in the field
of genome editing and immune diseases, formal coursework, and a research program that builds upon Dr. Kan's
strong experience in basic and clinical immunology with training in biochemistry, RNA expression, xenograft
mouse models, and lipid delivery of genome editors.
The overall objective of the research plan is to develop a non-viral platform technology for genome
editing of hematopoietic stem cells that comprehensively addresses all pathogenic mutations in each gene. As
over 1/3 of patients with ART-SCID have megabase deletions in DCLRE1C, the affected gene, the native locus
cannot be used for “universal” gene repair. The central hypothesis is that targeted integration of a DCLRE1C
transgene in the AAVS1 safe harbor locus will restore Artemis in ART-SCID, and the safe harbor will serve as a
platform for other IEIs. The specific aims are to 1) develop non-viral techniques of targeted integration to restore
Artemis expression in human hematopoietic stem and progenitor cells, initially ex vivo and then in vivo, and 2)
develop a novel assay for Artemis activity for both patient diagnosis and potency of gene-edited cell products.
This application is relevant to the NIH and the NIAID because Dr. Kan's goal is to develop methods for
genome editing that will improve outcomes for a devastating inherited immune disease and the technologies
developed will translate to other inborn errors of immunity.

Public health relevance
PROJECT NARRATIVE There are over 500 genetic diseases that cause problems with immune deficiency or dysregulation, and a major limitation to developing genome editing therapies at scale is the lack of methods that do not use viruses, which are challenging and expensive to manufacture and do not work equally well for all patient’s cells. Here, I propose to focus on one inherited immune disease, Artemis-deficient severe combined immunodeficiency (ART-SCID), and 1) develop a pre-clinical genome editing therapy using non-viral techniques and 2) develop methods to quickly and accurately determine if a patient has a true mutation in the gene that causes ART-SCID. If successful, this could be translated into a clinical trial for patients with ART-SCID and have broad implications for patients with other genetic disorders of the immune system.